REGULATION OF TRANSCRIPTS INVOLVED IN CORE 1 O-GLYCOSYLATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This project involves the transcript analysis of the core 1 galactosyltranferase and isoforms of it's chaperone protein Cosmc in human cells. This is our first analysis of transcript abundance of splice isoforms of a single gene product.